Development of two-dimensional (2D) acoustic force elastography microscopy for the non-contact measurement of elastic property of cell encapsulated scaffolds

ABSTRACT
Hydrogels play a key role in tissue engineering, providing a supporting structure to mimic a native extracellular
matrix (ECM) micro-environment for cell adhesion, proliferation and migration. As polymer networks infiltrated
with water, hydrogels are similar with human body, constituting most of their cells, extracellular matrices,
tissues and organs due to hydrophilic polymer networks infiltrated with water so that they have been widely
applied for diabetic wound healing, bioadhesive sealant and wearable device interface in biomedical
applications. An ideal engineered biomedical hydrogel's elastic properties should match well with the native
tissue that it is being integrated. In biomedical applications, mechanical interactions with dissimilar mechanical
stiffness between target tissues/organs and hydrogels can cause impaired functional efficacy such as foreign-
body response, tissue damage or scar formation. In tissue engineering, the mechanical stiffness of hydrogels
is dynamic because numerous features can influence their elastic properties such as cell adhesion,
proliferation, migration, levels of polymer molecular weights, levels of cross-linked collagens and cell density.
Therefore, characterizing hydrogel mechanical stiffness over time is critical. Mechanical tests such as dynamic
mechanical analysis (DMA) are the standard method to characterize hydrogel mechanical stiffness. However,
the major limitations of mechanical tests are that they are destructive measurements, multiple replicate
samples are required for studies with multiple time points and only global elasticity measurements are
provided. These limitations lead to difficulties for exploring the optimization of mechanical stiffness of hydrogels
to host tissues in biomedical and tissue engineering applications. In this proposal, 1) we will develop an
ultrasound-based elasticity measurement technique named two-dimensional acoustic force elastography
microscope (2D-AFEM), which can address current difficulties of mechanical tests and can repeatedly
measure 2D (x, y) Young's modulus of thin-layer cell encapsulated hydrogels. 2) To study 2D-AFEM
performance, we will test the 2D-AFEM elastography resolution, 2D Young's modulus of homogeneous and
heterogeneous hydrogel scaffolds, and validate experimental results by numerical simulation and DMA. 3) To
study how living cells affect stiffness changes of hydrogel scaffolds to obtain a desired functionality, we will use
2D-AFEM to explore elastic changes of cell encapsulated scaffolds and explore the relationship between
elastic changes and biochemical markers over time for longitudinal studies. The proposed 2D-AFEM will be a
promising modality to repeatedly and quickly evaluate 2D Young's modulus of living hydrogels over time to
explore the best match of the elasticity to host tissues for various applications in biomedical, tissue engineering
and biomaterial fields.

Public health relevance
PROJECT NARRATIVE An ideal engineered biomedical hydrogel should have elastic properties that match well with the native tissue that it is being integrated. Conventional mechanical testing methods have many limitations such as being destructive measurements. In this proposal, we will develop a new technique named two-dimensional acoustic force elastography microscopy (2D-AFEM) for characterizing elastic property of cell encapsulated scaffolds in various biomedical and tissue engineering applications.